Arizona Department of Health Services Laboratory - Special Project D3: Method Development EAM 4.12

Chemistry Tract 4 ? Capability and Capacity Development Narrative The Arizona Department of Health Services Laboratory (ASPHL) Chemistry program seeks to engage in a capacity development project to bring online Allergen testing using the MagPix System with XPonent 4.2 software. These efforts will be in coordination with the FDA and the resulting analytical method will be used by Arizona for food safety testing under Tract 2 - Human Food Product Testing. ASPHL Chemistry has a long history as a FERN cCAP Laboratory and specializes in method development work utilizing new technology to identify poisons and toxins in the US food supply.